Leadership, Planning, and Evaluation (LPE)

PROJECT SUMMARY – LEADERSHIP, PLANNING, AND EVALUATION
At the Salk Cancer Center (SCC), overall responsibility for planning and evaluation rests with the Director,
Reuben Shaw, PhD, who sets the vision and strategic processes to intensify the growth and impact of SCC’s
cancer research, training, and community impact. Shaw transformed SCC’s Senior Leadership team in 2021
with well-defined roles and responsibilities, enhancing the culture of engagement, input, and continuous
improvement. He embarked on refreshing SCC internal and external advisory committees and creating new
ones. Internal advisory bodies currently include the Executive Committee (EC), Research Program Planning
Committee, Shared Resource Management Group (SRMG), Cancer Research Training & Education
Coordination (CRTEC) Committee, and Plan to Enhance Diversity (PED) Committee. The External Advisory
Board (EAB) plays an essential role in the planning and evaluation process and has been revitalized in the
current funding period. Informed by these committees, Senior Leaders led several evaluation and transformation
processes during this cycle, including: 1) development of a new SCC Strategic Plan ; 2) reassessment of SCC
membership to improve cancer focus; 3) restructuring of Research Programs to achieve the goals of the Strategic
Plan and foster transdisciplinary collaboration and impact; and 4) evaluation of Shared Resources.
Building upon the successes of the prior strategic plan and to catalyze further strategic growth, the Specific Aims
of Leadership, Planning, and Evaluation are:
Aim 1. To lead efforts to execute the SCC Strategic Plan (2023-2028)
Aim 2. To leverage the talent and multidisciplinary expertise of a strong, collaborative senior leadership team,
as well as feedback from SCC members, Institute stakeholders, and internal/external advisory groups, to ensure
continuous improvement and innovation within the SCC Research Programs, Shared Resources, education and
training activities, and diversity initiatives.
Aim 3. To lead efforts to develop and execute the next Strategic Plan (2028-2033), thereby ensuring continued
excellence of the SCC.
Impact: During the current grant period, these rigorous planning and evaluation mechanisms have promoted
cohesion in planning and communication, guided proactive decision-making and new investments, and ensured
close monitoring of progress and timely course-corrections to foster the significant achievements described in
this component of the CCSG application.
A major achievement during the current funding period was the recruitment of a diverse set of new faculty
colleagues in the current grant period, including three accomplished female assistant professors. Notably, four
of the six new junior faculty hires were women or from under-represented minority (URM) groups or both as
gender equality in SCC leadership continues to be a major focus.